EVALUATION OF A 4KX4K CCD CAMERA FOR 300 KV MICROSCOPES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Both of our JEM3000 and JEM3200 electron cryomicroscopes are equipped with a Gatan 4kx4k CCD camera. Quantitative tests for its performance in terms of spectral signal to noise ratio at different frequencies are conducted with a variety of specimens including carbon film, protein crystals and single particles.